Expanding the targetable landscape in cancer with serine-targeting covalent ligands

Project Summary
Targeted covalent inhibitors have empowered the potent and selective targeting of driver oncogenes in
cancer. Between 2011 and 2021, 16 new covalent drugs (12 with cancer indications) were approved by the
US FDA, with the recent notable example of the first KRAS inhibitor sotorasib. However, most of current
covalent drug discovery efforts are directed toward cysteines, which is the least abundant amino acid in the
proteome (2%). Meanwhile, about 6% of mutants in cancer lead to serines. While some of these mutations
directly contribute to oncogenic signaling (e.g. KRAS G12S), others confer clinical resistance to existing drugs
(e.g. EGFR C797S, BTK C481S). To date, direct engagement of these mutant serines have not be achieved.
Methods to selectively engage amino acids beyond cysteine are highly desirable, as they will bridge the gap
between the prevalence of serine-acquiring mutations in human cancer and the lack of chemical tools to target
them.
This project aims to develop new chemistry that enables the covalent engagement of serine residues,
especially those acquired in cancer such as EGFR(C797S) (Aim 1) and BTK C481S (Aim 2). Successful
targeting of these proteins will provide new avenues for targeted cancer therapy. The chemistry developed in
this project will also serve as a platform for the discovery of new covalent ligands for currently “undruggable”
cancer targets (Aim 3).

Public health relevance
Project Narrative Many mutations (about 6%) in cancer lead to serines. Despite the prevalence of serine-acquiring mutations in cancer, methods to target them are scarce. This project will develop a new chemical strategy to target serines in cancer through a covalent mechanism and discover inhibitors for EGFR(C797S) and BTK(C481S), two commonly occurring oncogenic mutants.